BLR&D Research Career Scientist Award Application

Project Summary/Abstract:
The primary focus of our research group is to elucidate the underlying molecular mechanisms of pancreatic
(PDAC) and breast cancer (BC) pathogenesis. The overarching goal of our research is to investigate how the
cellular pathways (i.e., circuits) are dysregulated and can lead to uncontrolled cell growth (i.e., cancer). The
ultimate goal is to develop and use small molecules to target the dysregulated proteins to mitigate pancreatic
and breast cancers.
Our laboratory has been working with novel protein kinases with a short-term goal to define their
physiological functions (in cancer) and, in the long term, to identify their inhibitors or activators. We have been
working on kinases called Mixed Lineage Kinases (MLKs) and MAP4K4. The roles of MLKs and MAP4K4 in
cancer are an emerging area. Especially the inhibitor of the MLK family, CEP-1347, has gone through a clinical
trial for Parkinson’s disease, demonstrating no collateral toxicity. We have shown that inhibitor of MLKs can be
repurposed to treat Triple Negative breast cancer (TNBC) and PDAC in animal models.
Our recent results (previous VA-Merit) demonstrated that one of the MLK family members, MLK3, was
significantly overexpressed in human pancreatic cancer tumors and was necessary for cancer cell growth.
Moreover, MLKs inhibitor ameliorated PDAC tumor burden and extended the life of animals than vehicle treated
group in an aggressive animal model of PDAC (KPC). We plan to explore how MLK3 and MAP4K4 crosstalk
with other regulatory proteins and promote pancreatic cancer to determine the rationale for combination therapy
to mitigate PDAC. We recently reported (current VA-Merit) that another kinase, MAP4K4, is also overexpressed
in PDAC, and its inhibitor, GNE-495, similarly ameliorated the PDAC tumor burden in animals. However, in these
animals, the T cell co-stimulatory molecule, 4-1BB (CD137), was elevated, and thus combining GNE-495 and
agonistic-4-1BB antibody significantly reduced the tumor burden and extended the life of animals than the single
agent, (GNE-495) treated animals.
The other three projects [one NCI (no cost) and 2 DOD funded grants] are on breast cancer. We reported
earlier that suppression of MLK3 activity by estrogen and HER2 amplification was necessary for ER+ and HER2+
breast cancer cell survival and growth. Therefore, we developed a novel nanoparticle loaded with MLK3 activator
ceramide (PPP-CNP) that induced significant cell death in HER2+ and ER+ breast cancer cells. In animal models
of HER2+ breast cancer, the PPP-CNP was able to reduce tumor burden and overcome Trastuzumab (first-line
therapy for HER2+ BC) resistance (published in PNAS 2023). In human TNBC tumors, the activity of MLK3 was
very high compared to ER+ breast cancer tumors. We identified that another kinase, Pak1, is overexpressed in
TNBC and blocks the pro-apoptotic activity of MLK3. Based on our mechanistic data, the animals bearing TNBC
tumors (i.e., PDXs) were sensitive to MLKs inhibitors, dependent on TrkA expression in the tumors (published
in Oncogene 2023). The other two grants from the DOD are on breast cancer. The first grant is focused on
elucidating the roles of the MLK3-CD70 axis in mesenchymal BC. The Second grant focuses on understanding
the crosstalk between TrkA fusion proteins and MLK3 in BC.
Our comprehensive published and unpublished results corroborate that MLKs and MAP4K4 are viable
targets in breast and pancreatic cancers. Our results also suggest that activators of MLK3/MLKs could be useful
to treat ER+ and HER2+ breast cancer. In contrast, the inhibitors of MLK3/MLKs could serve as a therapeutic
intervention for TNBC and pancreatic cancer. Our comprehensive studies also suggest that understanding the
detailed roles of any given protein before considering it for targeted therapy is of utmost importance. We plan to
continue working on these clinically important kinases and take their inhibitors/activators for future clinical trials.

Public health relevance
Project Narrative: The incidence of certain types of cancer, including pancreatic (PDAC) and breast cancer (BC), is higher in veterans. It is predicted that by 2030, the PDAC incidence and mortality will be the second-highest. Our group focuses on understanding the basic mechanisms of PDAC and BC cell growth, identifying the targets, and developing drugs/inhibitors in collaboration. Protein Kinases are viable cancer targets, and some inhibitors are in clinical use. We have been working on protein kinases called MLKs and MAP4K4. We recently published that the inhibitors of MLKs and MAP4K4 reduced PDAC tumor burden and increased animal survival. With increasing numbers of female veterans, the incidence of breast cancer and developing resistance are quite frequent. Our research suggests that inhibitors of MLKs can also be used to treat Triple Negative Breast Cancer, a deadly sub- type that lacks drug targets. However, the activator of MLKs can serve as a therapeutic for ER+ and HER2+ BC and overcome resistance. We expect to take our discoveries to clinical trials in the future.